Utilizing Technology and AI Approaches to Facilitate Independence and Resilience in Older Adults

Abstract: Palliative care (PC) is an interdisciplinary concept aimed at improving the wellbeing of
persons with serious illness throughout their course of illness including end-of-life. PC enables
care decisions that align with patient and caregiver preferences. For persons with Alzheimer’s
Disease and Related Disorders (ADRD), PC is particularly challenging, as determining a patient’s
current status on the ADRD disease course is often difficult. Successful PC services in patients
with ADRD focuses on integrating therapeutic regimens with timely identification and alleviation
of physical, psychosocial, and decision-making needs of patients and their families. PC can
promote ethical, equitable, and efficient population health principles by achieving optimal
healthcare utilization by avoiding overuse and underuse. Many challenges hinder appropriate
levels of PC integration for persons with ADRD at both the patient- and population-levels. There
is ongoing discussion on optimal timing of PC delivery in addition to variation in availability of
well-trained teams and resources to deliver PC. One ubiquitous challenge is the care system’s
ability to identify those persons that will benefit most from PC. Moreover, there are documented
disparities in delivery of PC, such that minority race/ethnicity patients receive too little, too late
care compared to their majority counterparts. Artificial intelligence (AI) predictive modeling
techniques may enable accurate and timely identification of persons with ADRD who are likely to
benefit from PC assessment. To achieve our goal of using advanced AI analytic tools to improve
PC received by persons with ADRD, the project has the following objectives:1) To develop and
validate advanced predictive models (PM) to identify persons with ADRD who are likely to benefit
from PC assessment; 2) To evaluate the impact of PM based palliative care interventions on
population-level healthcare utilization outcomes; 3) To assess the disparities in PC services
delivery and healthcare utilization in African American and other minority populations with
ADRD; 4) To initiate first stage of technology transfer of the advanced analytic tools we develop
by undertaking initial pilots and developing both publicly accessible software and integration into
the JHU “ACG” population-based platform. Dr. Chintan Pandya (PI) and team will develop
machine learning prediction models to identify ADRD patients likely to benefit from PC
assessment. These models will be developed using data captured in electronic health record (EHR)
and other large electronic databases (e.g., insurance claims) of patients with ADRD cared for
within a large patient/consumer population. In addition to sharing open architecture free-access
tools at the conclusion of this project, we plan on integrating the software-based algorithms we
develop into our widely used (reaching 250+ million patients in 20+ nations) Johns Hopkins ACG
predictive modeling and disease stratification software. This will allow for rapid diffusion of new
palliative care analytic technologies among a very large U.S. and global healthcare organizations
client base. At the patient level, our ADRD PC decision support framework will promote
interactive goals of care discussions between patients/caregivers and providers. The populationbased analytic tools we develop will help promote resource planning, quality, and equity
assessment among ADRD cohorts within health delivery systems, health plans, and communities.

Public health relevance
Public Health Relevance: Palliative care (PC) improves wellbeing of persons with serious illness. For people with Alzheimer’s Disease and Related Disorders (ADRD), PC is particularly challenging, as determining patient’s status on the disease course is often difficult. The project aim is to apply AI algorithms using large databases to develop and disseminate digitally supported prediction models identifying persons with ADRD who would benefit from early PC. Our PC decision support framework will promote interactive goals of care discussions between patients/caregivers and providers. The knowledge generated will enable healthcare organizations and payers integrate our prediction modeling tools within their EHR platform for implementation and development of a workflow that supports routine care delivery of ADRD patient populations.